Loss of myeloid Paired Immunoglobulin-like Receptor B promotes atherosclerosis through inhibition of autophagy and metabolic rewiring

PROJECT SUMMARY
Cardiovascular disease (CVD) is the leading cause of death globally. The root cause of CVD is a chronic
inflammatory disease of the arterial wall called atherosclerosis. A critical determinant of atherosclerosis is
macrophage inflammatory phenotype. Within atherosclerosis, anti-inflammatory pathways are dysfunctional,
which results in pro-inflammatory stimuli driving macrophage phenotype. We have identified Paired
immunoglobulin-like receptor B (PirB) as a novel inhibitor of macrophage-mediated inflammation by facilitating
apoptotic cell digestion and promoting mitochondrial function. The aims of this proposal will determine the
mechanisms by which PirB inhibits inflammation through phagosomal and mitochondrial signaling pathways. We
will use macrophages containing a lysosomal reporter to track phagosome maturation and cargo fate.
Additionally, we will dissect the molecular mechanism by which PirB regulates mitochondrial metabolic function
and signaling.

Public health relevance
PROJECT NARRATIVE Chronically activated, pro-inflammatory macrophages are believed to be critical determinants of disease progression in atherosclerosis. I have identified the immunomodulatory receptor Paired immunoglobulin-like receptor B (PirB) as a novel regulator of macrophage pro-inflammatory phenotype through its ability to regulate non-canonical autophagy and mitochondrial stress. Understanding the mechanism by which PirB coordinates these two crucial pathways to dampen inflammation may reveal new therapeutic targets to treat arterial inflammation.